Metabolic rewiring coupled to the production of reactive oxygen and nitrogen species (RONS)

Project Summary/Abstract
Free radicals are more than toxic by-products of metabolism. Many cells produce reactive oxygen species (ROS)
and reactive nitrogen species (RNS) using specialized enzymes, NADPH oxidases (NOXs) and nitric oxide
synthases (NOSs) respectively, for specific functions. For instance, innate immune cells produce RONS in large
amounts during inflammation, and endothelial cells and neurons can produce them for signaling. RONS
production is an important part of many physiological processes as well as numerous diseases, including
inflammatory disorders, cardiovascular diseases, neurodegeneration, etc. We propose to investigate how NOX-
and NOS-dependent RONS production is coupled to substantial remodeling of cellular metabolism. Specifically,
we will address two key questions: (1) How is cellular metabolism remodeled to enable RONS production? Both
NOXs and NOSs require NADPH as the electron donor to drive the reactions. Thus, activation of NOX or NOS
greatly increases cellular NADPH demand and can significantly lower NADPH/NADP+ redox ratio. We recently
discovered that in activated neutrophils, NOX activation is quantitatively coupled to the metabolic shift from
glycolysis to cyclic pentose phosphate pathway (a unique mode for glucose metabolism with ultra-high NADPH
yield) to meet this demand. We propose to investigate the molecular mechanism allowing neutrophils to complete
such substantial metabolic switch in a very short time, which is essential for them to immediately mount the first
line of innate immune defense. We will next reveal the metabolic strategies other cells use to power up RONS
production using approaches including isotopic-tracing based metabolic flux analysis and genetic manipulation.
(2) How does the increase in RNS regulates cellular metabolism? It is well known that RONS can impact cell
functions through protein cysteine oxidation or nitrosylation. Intriguingly, we recently found that the inducible
RNS production in activated macrophages drives dynamic metabolic remodeling via a novel mechanism: RNS
specifically and efficiently inactivate two crucial mitochondrial enzymes, pyruvate dehydrogenase and
oxoglutarate dehydrogenase, via covalent modifications of the catalytic lipoic arm in their E2 subunits. We seek
to understand of the biochemical mechanisms for such RNS-driven regulation in-depth, specifically, (i) elucidate
the role of coenzyme A, the thiol-containing substrate for these enzymes, in delivering NO- mediated
modifications specifically onto the catalytic lipoic moiety; (ii) examine the mechanistic link between such lipoic
modifications with the cysteine nitrosylation on their E3 subunit; (iii) examine the reversibility of such RNS-
mediated modifications of lipoic arm and the mechanism driving the recovery. We will further investigate how
this mechanism regulates other lipoic arm dependent- enzymes, and elucidate the downstream effects of such
regulation in cellular physiology in various RNS-producing cells (e.g. regulation of pyruvate dehydrogenase by
NO can modulate histone acetylation and downstream cell functions by changing acetyl-coA availability).

Public health relevance
Project Narrative ROS and RNS production play an important role in various physiological processes (e.g. immune response, vascular regulation, neural functions) and in numerous pathological conditions. This study will provide a mechanistic understanding of how the remodeling of cellular metabolism powers up RONS production by NOXs and NOSs, and how their production causes downstream effects in metabolism and cell physiology. Such knowledge will provide a foundation to develop strategies to control RONS production or target the mechanisms for its downstream effects, which can modulate a broad range of physiological processes across tissues involving RONS production and improve the treatment of a variety of related diseases.